Staphylococcus aureus Type 7b Secretion System assembly and regulation

PROJECT SUMMARY
Staphylococcus aureus is a pervasive pathogen that causes invasive disease in humans. The type 7b secretion
system (T7bSS) of S. aureus transports a specific set of factors across the bacterial envelope, which are required
for S. aureus virulence and persistence in infected host tissues. Secretion of these proteins is dependent on the
expression of the ess operon, which encodes T7bSS structural proteins that assemble into a transport complex
within the bacterial envelope. The mechanisms of T7bSS expression and assembly are not well understood. Dr.
Bobrovskyy's research established a purification protocol for the T7bSS complex and identified accessory gene
regulator (Agr) and peptidoglycan hydrolase EssH as factors necessary to support T7b secretion. Thus, the overall
objectives of this proposal are to reveal the composition, stoichiometry and assembly of the purified T7bSS
complex (Aim 1), determine the mechanism whereby peptidoglycan hydrolase EssH supports T7b secretion (Aim
2), and elucidate T7bSS regulation by Agr (Aim 3). Together, these aims will test an overarching hypothesis that
the ess locus of S. aureus is regulated by the Agr pathway, leading to the assembly of the T7bSS complex that
spans the envelope and permits substrate translocation. In Aim 1, purification of the T7bSS complex coupled
with single-particle electron cryomicroscopy (cryo-EM) and cross-linking mass spectrometry will be utilized to
investigate the structural components that enable translocation of substrates across staphylococcal cell envelope.
In Aim 2, a combination of genetic and biochemical approaches will be used to investigate the contribution of
EssH to the assembly of T7bSS complex and substrate translocation across a thick peptidoglycan cell wall. In
Aim 3, the role of the post-transcriptional regulator RNAIII, a component of the staphylococcal Agr pathway,
and of other intermediate factors, will be examined for ess gene regulation. In addition, the proposed training
and career development activities are intended to provide Dr. Bobrovskyy with the experience and tools that will
allow him to successfully transition to independence in the field of bacterial physiology and pathogenesis. The
collaborative and interdisciplinary research environment in the Department of Microbiology at the University of
Chicago, and access to the state-of-the-art equipment at the core facilities, such as the Advanced Electron
Microscopy Facility, are well suited for the candidate's proposal. The candidate's mentors Drs. Missiakas and
Zhao, will assure the progress of the research and training objectives. Dr. Missiakas is an internationally
recognized scientist in the field of staphylococcal protein secretion, with a strong history of mentoring trainees,
many of whom went onto having careers in academia and industry. Dr. Zhao is a structural biologist who
specializes in cryo-EM analysis of membrane protein complexes and will provide training and support to the
candidate in this area. Dr. Bobrovskyy also assembled an advisory committee consisting of Drs. Phoebe Rice, Jim
Slauch and Sam Light, who will assist the candidate in his research and training. Overall, this award will enable
Dr. Bobrovskyy to attain his goals and propel his career towards independence.

Public health relevance
PROJECT NARRATIVE This project focuses on the Type 7b Secretion System (T7bSS) of Staphylococcus aureus where it facilitates persistent disease. The project examines the assembly and structure of this secretion system, the role of the peptidoglycan hydrolase EssH for the secretion of effector proteins and the mechanism whereby the Agr quorum sensing pathway controls this system. The T7bSS is poorly characterized and unique to pathogenic Gram-positive bacteria such as S. aureus, Listeria monocytogenes, Bacillus cereus and several Streptococci sp.